Identifying the molecular determinants of pterygium progression

Pterygium is a raised wedge-shaped fibrovascular growth of the conjunctiva that migrates into the transparent
cornea. Pterygium causes significant discomfort and can lead to a decline in vision through induction of
irregular astigmatism and obstruction of visual axis. The exact molecular mechanism leading to pterygium
formation and progression is unknown. Consequently, there are no available medical therapies available for
pterygium prevention or treatment. Inflammation biomarkers are upregulated in pterygium, and ultraviolet (UV)
exposure is the most significant risk factor for pterygium formation. However, the mechanism by which UV
exposure leads to inflammation, and whether an inflammatory response plays a causative role in pterygium
progression is unknown. Our preliminary data based on analysis of human pterygium samples and normal
conjunctiva demonstrate evidence of activation of non-canonical NF-κB signaling in human pterygia that is
coupled with de-repression of endogenous retroviruses (ERVs). ERVs are viral retroelements that have
integrated into the human genome, and their transcriptional de-repression has been associated with increased
cellular inflammation through the production of double-stranded RNA (dsRNA) and DNA (dsDNA), leading to
the activation of the dsRNA and dsDNA sensors, RIG-I/MDA5/MAVS and the cGAS-STING innate immune
pathways, respectively. Aberrant and dysregulated activation of cell-intrinsic, innate immune pathways has
been implicated in cellular migration and proliferation through activation of non-canonical NF-κB signaling. In
this proposal, we will test the central hypothesis that chronic UVB exposure induces transcriptional de-
repression of ERVs in conjunctival cells leading to increased cellular proliferation and migration through
activation of the cGAS–STING pathway and downstream non-canonical NF-κB signaling. This hypothesis will
be tested using two independent aims. Under Aim 1, we will test the epistatic dependency of the migratory
phenotype of pterygium-derived cells on non-canonical NF-κB signaling, which has been implicated in
mediating a migratory and invasive phenotype in cancer models. We will establish pterygium-derived cells
obtained from surgical specimens at our clinical practice. Under Aim 2, we will determine whether chronic UVB
exposure leads to upregulation of non-canonical NF-κB signaling, and test whether activation of non-canonical
NF-κB signaling is mediated by de-repression of ERVs and downstream cGAS-STING activation. By utilizing
genetic and pharmacologic manipulation of key components of the cGAS-STING and non-canonical NF-κB
signaling pathways, we seek to establish a mechanistic link between UVB exposure and a migratory
phenotype. The overarching goal of this proposal is to elucidate the molecular mechanisms underlying
pterygium formation and progression, and identify molecular targets that are amenable to pharmacologic
intervention. The Principal Investigator is an Assistant Professor at Yale University and runs an independent
laboratory. Our team has the clinical expertise and the resources to complete the proposed experiments.

Public health relevance
PROJECT NARRATIVE. Pterygium is a fibrovascular growth of the conjunctiva that extends into the transparent cornea, causing a decline in vision. Ultraviolet exposure is an established risk factor for pterygium formation, but the exact molecular mechanism leading to pterygium progression is unknown. Here we will test the hypothesis that ultraviolet radiation induces activation of endogenous retroviruses, which are otherwise suppressed at basal conditions, and in turn promoting cell migration via non-canonical NF-κB signaling.